Supplement to Multimodal Gating Mechanisms of TRPV1 Ion Channels

Project Summary The goal of this equipment request is to acquire a Fluorescence Lifetime Imaging Microscope (FLIM) upgrade to an existing microscope body/optics. The FLIM upgrade will provide a previously unavailable ability to measure the energetics of activation of pain-transducing TRPV1 ion channels.

Public health relevance
Project Narrative Although chronic pain is a major problem for our economy and the quality of life, current treatments are not very effective and have unwanted side effects. In this project, we will elucidate the fundamental biological mechanisms by which the pain receptor ion channel TRPV1 detects and integrates multiple types of painful stimuli, which will provide a new basis for the development of novel pain therapies.